Selective regulatory and biogenesis mechanisms for microRNAs

PROJECT ABSTRACT
microRNAs (miRNAs) are an abundant class of small regulatory RNAs that
typically derive from stepwise cleavages of hairpin transcripts by the Drosha and Dicer
RNase III enzymes. The resulting mature miRNAs mediate extensive networks of post-
transcriptional regulation, and are implicated in a variety of diseases including cancer.
This proposal extends our long-standing commitment to understand atypical and
regulated strategies for microRNA biogenesis and function. We build on long-standing
research efforts in the lab, as well as very recent developments and knowledge, to
propose three parallel directions on miRNA regulation. First, we will dissect regulatory
interactions within a miRNA operon, by which an optimal miRNA hairpin can benefit the
biogenesis of a neighboring suboptimal member (miRNA cluster assistance). Second,
we will uncover how multiple RNA quality control strategies suppress the biogenesis of
adventitious miRNA hairpin substrates derived from splicing (mirtrons and splicing-
derived, structured RNAs). These may play broad and unrecognized roles in regulating
host gene splicing. Third, we introduce data on a novel repressor of miRNA
accumulation and function (Alas), and endeavor to place its activity
Our studies utilize a wide variety of experimental and computational techniques,
and employ both Drosophila and mammalian systems. The data and insights gained
from this grant will extend fundamental knowledge on small RNA pathways, have
potential to help interpret genetic diseases involving miRNA dysfunction, and may
eventually underlie improved methods for therapeutic RNAi.

Public health relevance
PROJECT NARRATIVE microRNAs are an extensive class of ~22 nucleotide RNAs that mediate broad networks of gene regulation, and their dysfunction is linked to disease and cancer. Using both Drosophila and mammalian systems, we uncovered several new mechanisms that govern regulated and/or selective microRNA biogenesis. We will integrate biochemical, molecular, genetic and genomewide approaches to elucidate new strategies that ensure specific and efficient generation of how microRNAs from proper substrates, and how their activity as silencing molecules is controlled.